Multidisciplinary Training Program in Pediatric Pulmonary

Project Summary
The goals of the Johns Hopkins Multidisciplinary Training Program in Pediatric Pulmonary Medicine (T32) are
to: (1) produce outstanding biomedical scientists who will investigate the pathophysiology and treatment of
pediatric pulmonary disorders; (2) encourage and enable post-doctoral fellows to pursue academic careers in
clinical and biomedical research; (3) train physician-fellows to fill one of the most important health-related
needs of the nation: translational medical research with a focus on pediatric pulmonology; and (4) develop
national leaders in pediatric pulmonology. The program is committed to equal opportunity for its faculty, staff
and students and does not discriminate on the basis of any legally protected characteristics. The proposed
training program will provide three years of training in pediatric lung-related research at the postdoctoral level
for qualified candidates with an MD, MD/PhD, or DO degree and 1-3 years of training for qualified
candidates with PhD degrees. We are requesting support for 4 post-doctoral fellows/year. This training
program is the result of an extensive collaboration between 25 research faculty members in the Johns
Hopkins School of Medicine's Departments of Pediatrics, Medicine and Nanomedicine. These research
scientists offer mentored training in five Research Discipline Groups: (1) cystic fibrosis, epithelial
transport, mucus rheology and transport ; (2) lung injury and development; (3) clinical outcomes in
pediatric pulmonary diseases; (4) infectious diseases, tuberculosis and global health; and (5) asthma, allergy
and inflammation. The tutorial relationship between research-preceptor and trainee will be central to the
program's research training experience. This will be supplemented by formal training in clinical investigation,
preparation of grant applications and the responsible conduct of research, participation in program-wide
conferences, presentation of original research at national scientific meetings and publication of original
research in peer-reviewed journals. The Program Director will have overall responsibility for coordination of
the program, including its scientific, educational and administrative aspects. She will receive consultation
from an Advisory Committee and from Minority Advisory and External Advisory Committees. The Program
Director will be assisted in the day-to-day operations of the program by the Chair of the Advisory
Committee, who will oversee the research training of this T32 program and by the head of Fellow Education
and Division Administrators. Although only 14 years old, this Multidisciplinary Training Program in Pediatric
Pulmonary Medicine (T32) at Johns Hopkins has graduated 16 highly trained physician-researchers in
pediatric pulmonology, 12 of whom are establishing research programs as faculty members in academic
institutions in the US. This high performance record will be continued in the proposed program.

Public health relevance
Basic, translational, and clinical research involving studies of the mechanisms of pediatric respiratory diseases and therapies for these diseases lags behind research in adult pulmonary disease, at all levels. This is despite the fact that the onset of lung disease in childhood is a strong predictor for respiratory disease in later life and prevention and/or treatment of childhood respiratory diseases has the potential to significantly reduce disease and medical costs associated with disease in later life. The proposed training program will address this glaring need for academic pulmonologists who will establish research programs and continue to train the leaders of tomorrow. Although only 14 years old, this T32 training program in the Eudowood Division of Respiratory Sciences at Johns Hopkins has graduated 16 highly trained physician- researchers in pediatric pulmonology, 12 of whom are establishing research programs as faculty members in academic institutions in the US. This high performance standard will be continued in the proposed program.